Sleep Apnea-Specific Nocturnal Blood Pressure Surge to Determine Cardiovascular Risks and Therapeutic Benefits in Patients with Obstructive Sleep Apnea

Project Summary
Individuals with Down syndrome (DS) (I-DS) are at a heightened risk of obstructive sleep apnea
(OSA). Despite the well-established association of OSA with cardiovascular (CV) risks in the
general population, whether such an association exists in I-DS is unknown. Despite the high
rates of risk factors such as OSA and obesity, there is a suggestion of a lower risk of
hypertension and atherosclerotic CV disease (CVD) in I-DS. In this regard, whether increased
CV risks are present in I-DS with a high burden of OSA is uncertain. Clarifying the CV impact of
OSA may unveil one mechanism by which I-DS are protected from these CV conditions. To
address this, we propose a time-sensitive and cost-efficient supplementary study to the NHLBI-
sponsored “Sleep Apnea-Specific Nocturnal BP Surge to Determine CV Risks and Therapeutic
Benefits in Patients with OSA study R01HL158765” (SASBP study, Project period: 2021-2026).
The scope of this project is within the scope of the parent study, which aims to identify blood
pressure and other physiological responses to OSA as a way to explain the mediating
mechanism of OSA and subclinical CV disease. This study would allow us to assemble a cohort
of I-DS across the lifespan to perform deep phenotyping and study co-existing conditions
(INvestigation of Co-occurring conditions across the Lifespan to Understand Down syndromE
[INCLUDE] component 2) and to conduct clinical trials research inclusive of I-DS (INCLUDE
component 3). We will recruit I-DS and control groups with OSA to achieve the following Aims.
Aim 1 is to test the hypothesis that immediate CV consequences of OSA events are attenuated
in I-DS compared to those without DS. We will compare immediate CV consequences (changes
in heart rate and estimated blood pressure) with those of age-, sex-, BMI- and OSA severity-
matched (n=15 each group). We will also compare the severity of OSA-related hypoxemia
(hypoxic burden) and arousal tendency. Aim 2 is to test the hypothesis that in the presence of
OSA, markers of subclinical CV disease are attenuated in I-DS than those without DS. We will
compare daytime and nocturnal BP, arterial stiffness, and global longitudinal strain by
echocardiography between the two groups. We will also examine the association between the
degree of immediate CV consequences and the subclinical CV disease. This represents an
inclusive mechanistic study focusing on I-DS with OSA, a major comorbid condition in this
special population. The study's findings will facilitate risk stratification of I-DS with OSA and
provide pivotal preliminary data to design future clinical trials to test the efficacy of OSA therapy
in health outcomes of I-DS.

Public health relevance
Project Narrative A high proportion of individuals with Down syndrome (I-DS) have obstructive sleep apnea (OSA). While OSA is linked to increased cardiovascular risks in the general population, whether such a link exists in I-DS is unclear. We propose to study the effect of OSA on cardiovascular responses during sleep and assess the overall cardiovascular risks in I-DS.